Integrating genomics and EHR to accelerate precision psychiatry

Precision psychiatry aims to provide more targeted prevention, personalized risk prediction, and tailored
treatments by stratifying patients based on a variety of risk factors, including genetic biomarkers. However, three
major factors limit the translation of genomic findings to clinical practice, namely: (1) genetic predictors are
trained largely on Eurocentric genome-wide association studies (GWAS) distinguishing disorder cases from
controls, rather than on clinical outcomes with greater relevance to patients and clinicians, (2) genomic predictors
are often general indices of polygenic risk capturing average effects across disorder subtypes, limiting their ability
to more precisely parse heterogeneity in patient profiles, and (3) translational models often fail to capture
complex nonlinear relationships, including interactions among genetic predictors or between genetic and clinical
risk factors. The proposed work is designed to address each of these gaps.
In this proposal, Dr. Tubbs will derive etiological insights into more clinically-relevant psychiatric phenotypes and
build translational models to predict these traits in large diverse samples by integrating genomic data with
information contained in electronic health records (EHRs). Specifically, Dr. Tubbs will develop phenotyping
algorithms for defining three clinical course traits (age at onset, treatment response, and hospitalization), perform
multi-ancestry GWAS meta-analyses, and assess phenotyping quality using genetic validation (Aim 1). Dr. Tubbs
will also apply a novel approach for dissecting heterogeneity by identifying cross-disorder latent genetic traits
using publicly-available GWAS summary statistics (Aim 2). Finally, he will apply a state-of-the-art SuperLearner
framework to predict clinical course traits using multi-dimensional polygenic scores (PGS) and EHR-derived risk
factors (Aim 3). Together, these aims will uncover novel insights into trans-diagnostic etiology and build
translational models for precision psychiatry, while serving as a foundation for a future R01 grant proposal.
With his existing skills in statistical/psychiatric genomics, demonstrated productivity, and strong mentorship team,
Dr. Tubbs is well-positioned to complete the proposed research and training objectives. Through a combination
of coursework, mentorship, and leadership activities, the proposed training plan will strengthen the candidate’s
skillset in four key areas: advanced EHR phenotyping, machine learning fundamentals, clinical-translational
research principles, and grant-writing/leadership. Dr. Tubbs will continue to be mentored by Drs. Tian Ge and
Jordan Smoller, while receiving critical support towards his research and training goals from several collaborators
with expertise in EHR phenotyping (Dr. Lea Davis), statistical genetics (Dr. Cathryn Lewis, Dr. Hailiang Huang),
and psychiatric machine learning (Dr. Jyotishman Pathak, Dr. Colin Walsh). Overall, this K01 award will be pivotal
in Dr. Tubbs’ progress towards establishing an independent research career focused on precision psychiatry.

Public health relevance
PROJECT NARRATIVE Developing more personalized prevention and treatment options is the goal of precision psychiatry, but efforts to translate findings from psychiatric genomics have been limited by several factors related to data availability and methodological approach. In this proposal, we propose an innovative approach to address these challenges by (1) performing large-scale genetic studies of clinically-important phenotypes derived from electronic health records, (2) identifying data-driven genetic latent traits that move beyond pre-defined disorder boundaries, and (3) leveraging machine learning, big health data, and multiple genetic measures to train predictive models. In addition to building translational predictive models designed for clinical use, insights from genetic studies will lay the groundwork for future research to identify novel treatment targets and develop more precise interventions.